Project 1: Epigenetic variations associated with aggressiveness in prostate cancer among Puerto Rican men

This project addresses health drivers that contribute to differences in prostate cancer (PCa) outcomes in our
catchment area. While socioeconomic status and access to healthcare are contributors, manifest differences in
molecular features between groups within our catchment area highlight the role of tumor biology in disparate
outcomes in PCa. Our long-term goal is to identify DNA methylation biomarkers driving gene expression changes
that underlie PCa therapy resistance and aggressiveness in at-risk populations. The central hypothesis is that
differences in tumor DNA methylation patterns and population admixture are associated with drug response and
aggressiveness in PCa. The rationale is that identifying the molecular basis of PCa differences will serve to
reduce the burden of lethal PCa affecting Americans. Our goals will be accomplished through two Specific Aims:
Aim 1) Investigate associations between aggressiveness and methylated genes in PCa, addressing health
drivers of cancer outcomes in PCa patients and compare with methylation data from the Florida PCa biobank,
and PCa patients from MCC, and TCGA. (1b) Evaluate differential DNA methylation on gene expression
patterns. We will establish comparisons with previous data obtained from MCC and TCGA. (1c) Evaluate whether
population admixture will modify the methylation level of specific methylated genes. Further, we will investigate
whether genes that contain genetic variability determinants are associated with the aggressiveness of PCa and
outcomes. Aim 2. Assess the contribution of DNA methylation to PCa resistance to standard therapies using
drug-resistant PCa sublines and liquid biopsies from PCa patients progressing after treatment. (2a) Identify
differentially methylated genes associated with drug-resistant phenotypes using cell-based models of drug
resistance, including castration resistance, enzalutamide resistance, and docetaxel resistance. (2b) Evaluate the
expression of differentially methylated genes in resistant sublines compared to sensitive cell lines. (2c) Assess
the effect of DNA methylation inhibition on drug sensitivity in resistant phenotypes. (2d) As an exploratory aim,
we will evaluate resistance-associated methylation profiles in blood samples from PCa patients from our
catchment areas previously treated with androgen deprivation therapy, androgen receptor-targeting agents, or
taxane-based chemotherapy. The identification and validation of novel DNA methylation signatures associated
with aggressive and drug-resistant PCa have the potential to improve risk stratification and treatment selection
in patients with PCa.